Targeting Renal Tubular Epithelial Progenitors in AKI to CKD transition

Project Summary/Abstract
Dysregulated renal repair/regeneration leads to the development of chronic kidney disease (CKD) after acute
kidney injury (AKI). However, there are no effective treatments to improve the renal repair/regeneration process,
and the dearth of therapeutic options leaves affected patients at high risk of CKD progression and CKD-
associated cardiovascular events and mortality. This unmet medical need underscores the importance of
identifying new therapeutic strategies by elucidating the molecular underpinnings of impaired renal repair. Highly
regenerative SRY-box 9 (SOX9)-expressing tubular epithelial cells (hereafter, Sox9-progenitors) were recently
identified as a critical cell population for healthy renal repair. We found that Sox9-progenitors become
dysfunctional, losing their regenerative function after severe but not mild AKI. Our extensive preliminary data
further indicate that excess oxidative stress contributes to the dysfunction of Sox9-progenitors through
ferroptosis, a newly identified form of oxidative-stress-induced, non-apoptotic regulated cell death that is
observed in human AKI. Our preliminary data also underscore the therapeutic potential of harnessing anti-
ferroptotic defense pathways to enhance renal epithelial repair and avert progression to CKD. However,
molecular mechanisms underlying oxidative stress-induced Sox9-progenitor dysfunction remain unknown, and
the contribution of ferroptosis to the AKI-to-CKD transition requires elucidation. To advance this promising and
clinically relevant line of investigation, we will test our central hypotheses that: (1) In the setting of severe tubular
oxidative stress in AKI, Sox9-progenitors become dysfunctional, impeding renal repair/regeneration, and (2)
excess lipid-peroxidation in Sox9-progenitors induces ferroptosis, precluding healthy healing of damaged renal
tubules, thus driving progression to CKD. To test these hypotheses, we will integrate unbiased single-cell
transcriptomics and mouse genetics in two Specific Aims. In Aim 1, we will determine the mechanisms of Sox9-
progenitor dysfunction at single-cell resolution by comparative analyses of kidneys that underwent severe versus
mild ischemic renal injuries. In Aim 2, we will investigate ferroptosis in Sox9-progenitors as a key driving
mechanism of the AKI-to-CKD transition by genetically deleting the anti-ferroptotic defense enzyme, glutathione
peroxidase 4, from the Sox9-progenitors. We will subject our gene-modified mouse lines to ischemic, toxic, and
obstructive renal injuries to define the contribution of ferroptosis of Sox9-progenitors across the spectrum of
different AKI etiologies. Completion of these aims will allow us to identify molecular mechanisms of maladaptive
renal repair and elucidate the fundamental pathogenic roles of ferroptosis in renal tubular epithelial progenitors.
Our results will lay the scientific foundation for activating anti-oxidative and anti-ferroptotic pathways to enhance
renal repair/regeneration as a novel therapy to disrupt the AKI-to-CKD transition.

Public health relevance
Project Narrative Acute kidney injury (AKI) afflicts 1.2 million hospitalized patients annually in the US, and 20-50% of survivors of AKI progress to chronic kidney disease (CKD) as a result of failed renal repair. There are no available therapies to enhance renal repair/regeneration, underscoring an immense unmet clinical need. In this application, we seek to determine molecular mechanisms that underlie how oxidative stress impedes renal repair/regeneration and establish a proof of principle that activating anti-oxidative stress pathways can enhance renal repair and prevent the AKI-to-CKD transition.